Establishing Fidelity of Neurodiversity-Affirming Interventions

Project Summary
Interventions to support clinical and behavioral needs of autistic people are among the most resource-
intensive in any field. While it is crucial to advance the use of empirically-supported interventions for this
population, it is yet more pressing to understand factors that drive intervention decision-making among
practitioners and families regardless of empirical status. With the rise of the neurodiversity movement, which
deprioritizes the goals of normalizing behavior or eliminating autism, there has been a rapidly-growing
appreciation from stakeholders for interventions consonant with such values, grounded in the experiences of
autistic people and other members of the autism community, while still impacting important outcome domains.
Thus, the aspiration to implement so-called neurodiversity-affirming interventions (NAI) has become a
touchstone in the autism stakeholder community as a marker of value and utility. Indeed, many practitioners
are changing the way their practices are advertised to highlight their purported use of NAIs, and families are
increasingly considering the NAI label when making decisions about the services they choose for their children.
This can directly impact whether families elect to engage in any intervention at all, irrespective of empirical
status. However, while NAI is quickly emerging as a new practice domain, no consensus exists about what
constitutes a NAI. With scant empirical or theoretical literature, there is no operationalization of the term, and
vast space for ambiguity, creating a “carts before horses” problem. Indeed, this has created a crisis for the
field, making it impossible to ask empirical questions about whether NAIs impact target outcomes, how they
align (or do not) with evidence-based practices, who is doing NAIs, and what features of NAIs cohere as an
identifiable practice set. Thus, a tool to measure fidelity of NAI implementation is urgently needed. The goal of
this project is to produce such a measure. This project aims to leverage qualitative interviews of relevant
experts (autistic individuals and caregivers) to establish a pool of items indicating what they see as the
outcomes most affected by NAIs. It will then draw from a national sample to establish a comprehensive, NAI
measure that also group-specific variation by of a) autistic individuals, b) caregivers, and c) practitioners, using
the initial item set by implementing a multi-round Delphi poll approach to establish consensus. Finally, this
study will administer a large national survey of practitioners across clinical and behavioral disciplines that work
with autistic individuals, examining internal consistency of the Fidelity measure and its 3 subscales (autistic
individuals, caregivers, practitioners), as well as convergent and divergent validity of the measures across
practitioner groups, considering demographics, training, outcome targets, and discipline. This work will provide
a foundation for future study of NAI, providing a tool to examine the discrete and additive effects of NAI
implementation on outcomes in a wide array of evidence-based and community-derived intervention settings.

Public health relevance
Project Narrative We aim to utilize autism stakeholder perspectives (autistic adults, caregivers, and clinicians) to establish a stakeholder-consensus (between autistic adults, caregivers, and clinicians) driven measure defining key elements for neurodiversity-affirming interventions (NAIs) for school-aged and adolescent autistic youth. The utility of this NAI Fidelity measure as a tool for NAI implementation will be examined in a national US sample of clinical and behavioral practitioners that work with autistic youth. This project will benefit public health by improving understanding of access and engagement of interventions for autistic youth.